The Role of Astrocyte Elevated Gene-1 (AEG-1), A Novel Multifunctional Protein, In Chemotherapy-Induced Peripheral Neuropathy

Abstract
Chemotherapy-induced peripheral neuropathy (CIPN) is a prominent dose-limiting side effect of chemotherapy
treatment and will often result in the discontinuation of a treatment regimen for cancer patients. Taxanes, such
as paclitaxel (PAC), are a class of chemotherapeutics that fall into this “high prevalence” category of drugs.
There are currently no FDA approved prophylactic or treatment regimens designated to ameliorate CIPN.
Peripheral inflammation is a common neurotoxic mechanism among many of the chemotherapeutic agents
with a high prevalence of CIPN development in patients. PAC is known to activate peripheral macrophages,
leading to a cytotoxic inflammatory response that contributes to the development and maintenance of
peripheral neuropathy. Astrocyte Elevated Gene 1 (AEG-1) is a multifunctional protein that operates in a wide
variety of intracellular signaling pathways. It has been shown to regulate macrophage activation and mediate
cellular inflammation through direct interaction with Nuclear Factor kappa B (NFκB), a key transcription factor
protein which regulates the expression of multiple proinflammatory cytokines (PIC). Our preliminary studies
demonstrate that nociceptive behaviors and increase in PIC in the dorsal root ganglia (DRG) of mice treated
with PAC were significantly reduced in AEG-1 global knockout (KO) mice compared to AEG-1 WT mice,
without affecting motor activity and coordination of the animals. We also present data that shows PAC
administration increases AEG-1 (MTDH) expression in the DRGs of WT male mice and peripheral
macrophages collected from C57BL/6J mice. These findings identify a key role of AEG-1 in regulating
nociceptive responses and a potential target for ameliorating CIPN. We hypothesize that AEG-1 mediates
PAC-induced neuroinflammation, via macrophage activation leading to the development of CIPN. We will test
our hypothesis in Aim 1 by analyzing pain behaviors and various aspects of neuropathy in paclitaxel-induced
CIPN in AEG-1 KO and WT mice. We will also assess mRNA expression levels of PIC and protein levels of
phosphorylated NFκB in the DRGs collected from PAC treated mice to determine how global AEG-1 deletion
impacts PAC-induced neuroinflammation in an NFκB-dependent manner. Aim 2 will investigate the role of
macrophage cell AEG-1 expression in PAC-induced neuropathy and neuroinflammation by using myeloid cell-
specific conditional AEG-1 KO mouse. Completion of these behavioral and molecular studies will identify
AEG-1 expression, particularly in macrophages, as a key driver of neuropathy paving the way for novel
therapeutic targets for the treatment or prevention of CIPN.

Public health relevance
Project Narrative Chemotherapy-induced peripheral neuropathy (CIPN) is a prominent dose-limiting side effect of chemotherapy treatment and will often result in the discontinuation of a treatment regimen for cancer patients. This proposal seeks to investigate the role of Astrocyte Elevated Gene-1 (AEG-1) in paclitaxel-induced peripheral neuropathy and associated neuroinflammation. Our studies will identify AEG-1 as a novel and crucial regulatory molecule modulating neuropathy and will pave the way for developing novel therapeutic strategies to treat and/or prevent the development of CIPN.